Core 2: Biostatistics Shared Resource Core

PROJECT SUMMARY: BIOSTATISTICS AND BIOINFORMATICS SHARED RESOURCE CORE
In this application, we propose to intensify the role of our existing Meharry Medical College/Vanderbilt-Ingram
Cancer Center/Tennessee State University Cancer Partnership (MVTCP) Biostatistics and Bioinformatics
Shared Resource Core (BBSRC). The BBSRC will support the proposed two full projects and one pilot project;
detailed and specific biostatistical and bioinformatic analysis plans are provided for each specific aim/sub-aim
within each project. Sample size for each primary experiment is computed to provide high power to detect
clinically or biologically relevant effects. For projects with high-dimensional data analyses, the methods described
in the Research Strategy will be applied to assess data quality and then perform statistical analysis only after
preprocessing to address quality issues. BBSRC support is required for all MVTCP studies, with biostatisticians
and bioinformaticians from this core assigned to each project. BBSRC personnel have worked and will continue
to work closely with project leaders to ensure the Biostatistics and Bioinformatics Shared Resource Core
provides state-of-the-art statistical/bioinformatic support to the MVTCP.